Immunotoxins based on the IgG response to autologous antigens in cancer patients

? DESCRIPTION (provided by applicant): Lung cancer is the leading cause of cancer death in the United States, but the promise of therapies based on monoclonal antibodies (mAbs) has been unrealized due to the lack of known antibody targets specific for lung cancer cells. This research will address this need by characterizing three new lung cancer-specific mAbs that were cloned from patients with cancer and have shown cytotoxic activity in vitro when converted into antibody drug conjugates. We will convert them into immunotoxins and test them for and determine their specificity, safety and efficacy against lung cancer.

Public health relevance
PUBLIC HEALTH RELEVANCE: Lung cancer is the leading cause of cancer death in the United States, with almost 160,000 deaths estimated for 2014. An important approach for treating NSCLC uses monoclonal antibodies (mAbs) incorporated into structures that enable enhanced cancer killing, such as Antibody Drug Conjugates (ADCs), Bi-specific T-cell Engagers (BiTEs), and Chimeric Antigen Receptors for T-cell expression (CARs). New NSCLC-specific antigens are needed to realize this potential. This research will analyze antibodies made by a novel process of target discovery, analyzing the antibody response that patients make against their own tumors. Here, we will evaluate the clinical utility of patient-derived anti-NSCLC mAbs and the antigens they recognize by converting the mAbs into immunotoxins (IMMTXs) for functional testing in vitro and in vivo. IMMTXs combine a targeting moiety, such as a mAb, with a bacterial or fungal toxin. For this study, we will use a 3rd generation, deimmunized Sarcin, a ribotoxin from the mold Aspergillus giganteus. The structure, stability, and pharmacokinetics of the IMMTXs will be assessed. Anti-tumor efficacy will be evaluated in vitro with cultured cell lines and in vivo in murine xenografts. We will also identify the specific target molecule recognized and measure its copy number and mAb binding affinity. These experiments will establish the activity, safety and in vivo efficacy of human mAb targeted IMMTXs. The successful completion of these studies will provide a rationale for these novel IMMTXs towards clinical development. Furthermore, the characterization of a human mAb that reveals a valid target for cancer immunotherapy will encourage further efforts to discover new cancer-specific antigens by studying the antibodies that cancer patients make against their own tumors.